Multidisciplinary Research Fellowship in Alzheimer's disease and Related Dementias

ABSTRACT
This is the third renewal application requesting T32 funding for the UCSF Behavioral Neurology Training Program
(BNTP), co-directed by Drs. Howard Rosen and Bruce Miller. The BNTP was established at UCSF in 1999 within
the UCSF Memory and Aging Center (MAC) to train clinical researchers in behavioral neurology and
neurodegenerative disease. Funded in 2005, this T32 program allows emerging researchers to gain an
integrated understanding of the clinical, epidemiological, genetic, and molecular features of neurodegenerative
diseases, and is one of the few programs in the world that provides intensive training on the non-Alzheimer’s
dementias and non-amnestic forms of AD. The goal of the program is to train postdoctoral clinical researchers
for a career in neurodegenerative research. The program is open to MD neurologists, geriatricians and
psychiatrists who have completed a residency. A core element of our program is accurate classification of
dementia subtypes and prediction of the specific proteins causing neurodegeneration. Our training is designed
to impart fellows with the skills to evaluate and quantify the effects of various proteins and other biological factors
that cause dementia using clinical assessment and laboratory methods. Training takes place over two years.
The first year consists of research rotations through four clinical research programs at our center including our
program project grant on frontotemporal dementia, our Alzheimer’s disease research program, our rapidly
progressive dementia program and our clinical trials program. During this year, fellows begin development of
their research project with one of the program mentors and develop skills in scientific writing, presentation, and
in data analysis using archival data from our clinical and imaging databases. In the second year, fellows are
given more unstructured time to continue their research project and plan for grant submissions to support their
future career in clinical research. Over the years, our program has strengthened relationships with UCSF
Psychiatry and Geriatrics, and this has influenced our research, recruitment, and approach to training. Twenty-
nine fellows have been supported directly by this T32, but the infrastructure developed through the T32 program
contributes to the education of many additional postdoctoral fellows. In the upcoming cycle the training program
will include additional didactic sessions covering social determinants of health, health economics and policy,
along with leadership training.

Public health relevance
PROJECT NARRATIVE The proposed grant would support the training for postdoctoral MD trainees who are planning a career in clinical research in Behavioral Neurology and neurodegenerative disease. The program is led by Drs. Howard Rosen and Bruce Miller, both experienced researchers, and provides fellows with an integrated understanding of the clinical, epidemiological, genetic, and molecular features of neurodegenerative diseases. The goal of the program is to train future academic researchers.